A Novel Framework for Sensitive and Reliable Early Diagnosis, Topographic Mapping, and Stiffness Classification of Colorectal Cancer Polyps

Summary/Abstract:
Our long-term goal is to develop a novel soft robotic endoscope with intelligent tactile sensing balloons and
complementary machine learning (ML) and computer vision (CV) algorithms to enhance early-stage detection,
accurate tumor localization, and treatment stratification of various gastrointestinal (GI) cancers. This robotic
framework provides clinicians with (i) a safe and intuitively-steerable soft robotic endoscope to perform precise
diagnosis, biopsy, and surgical procedures; (ii) in vivo high-fidelity visual, textural, and stiffness information of
the diagnosed anatomy; (iii) in vivo radiation-free quantified topographic mapping and morphological
characterization (i.e., shape and texture) of GI polyps using CV algorithms; (iv) intelligent real-time in vivo
classification of type and stiffness of detected polyps using ML algorithms; and more importantly (v) quantitative
evaluations of tumor response during chemo- and radiation-therapy period via in vivo topographic/stiffness
mapping. Considering the 2-year timeline of this collaborative project, in this proposal, we will mainly
focus on the design, development, and thorough evaluation of a novel and soft Vision-based Tactile
Sensing Balloon (VTSB) with complementary Computer Vision (CV) and Machine Learning (ML)
algorithms to perform high-resolution in vivo topographic mapping and stiffness classification of
Colorectal Cancer (CRC) polyps.
CRC is the leading cause of cancer incidence and mortality worldwide. In 2020, CRC accounted for 1.9 million
new cases (i.e., #3 cancer type in ranking) and 935,000 new deaths (i.e., #2 cancer type in ranking). Since
survival outcomes differ significantly based on the tumor stage at the time of detection, early detection via
colonoscopy has a significant impact on treatment outcomes. Morphological characteristics (i.e., shape and
texture) and change in the modulus of elasticity of CRC polyps are well-known to be associated with tumor type
and stage. Colonoscopic procedures, therefore, are of paramount importance as they can help in early detection
and removal of pre-cancerous polyps. However, state-of-the-art traditional colonoscopic procedures still solely
rely on visual 2D/3D images and cannot yet provide the clinicians with in vivo detailed textural and stiffness
feedback. These limitations has caused high polyp miss rate (about 20%-30%) as well as heavily subjective and
evaluator-dependent tumor identification and classifications.
It is our central hypothesis that utilizing the proposed VTSB with complementary ML and CV algorithms, can
collectively address the limitations of the state-of-the-art colonoscopic technologies by (1) readily integrating with
the existing colonoscopic systems and not changing the current clinical diagnosis workflow, (2) providing high-
resolution 4D imaging (3D texture mapping + stiffness classification), (3) decreasing polyp miss-rate, and (4)
enhancing in vivo polyps’ type and stage classification. The proposed contribution is significant, high impact, and
innovative and our goal is to demonstrate that it can significantly improve the current diagnosis procedures and
shift the current clinical paradigm.

Public health relevance
PROJECT NARRATIVE This project aims to improve early diagnosis of colorectal cancer polyps by development of a novel and soft tactile sensing device and complementary intelligent algorithms. The proposed transformative diagnosis framework (1) readily integrates with the existing colonoscopic systems and does not change the current clinical diagnosis workflow, (2) provides high-resolution 4D imaging (i.e., 3D texture mapping + stiffness classification), (3) dramatically decreases polyp diagnosis miss-rate, and (4) enhances in vivo polyps’ type and stage classification.